Development of nanodroplet enhanced ultrasonic cavitation technologyto enable the study of chromatin accessibility in FFPE tissues

Abstract
Triangle Biotechnology is developing ChromExtract™, a low-cost, nanodroplet-based sonication reagent for
chromatin extraction from formalin-fixed paraffin-embedded (FFPE) tissues for downstream chromatin profiling
and chromatin accessibility analyses. These techniques are central to epigenomic research and mapping of
histone modifications, enhancers, and chromatin states, enabling systematic investigation of epigenomic effects
on cell identity, development, lineage specification, and disease. While chromatin profiling analyses have been
used for over two decades, several bottlenecks exist that have prevented epigenetic profiling from yielding
consistent and reliable data from FFPE tissues, most notably the poor quality and yield associated with current
chromatin extraction methods. This is a considerable problem, as most translational research and clinical
diagnostics employ FFPE tissue specimens. Moreover, compatibility with FFPE tissues provides access to a
massive bank of archival samples that can be used to further characterize molecular subtypes for pathologies of
interest. Given the current state of the field, a rapid, high-yield, and high-efficiency method for extraction of
chromatin from FFPE tissue that results in improved chromatin quality and standardization across sample types
would have a significant impact on the field and potential applications for studying chromatin accessibility and
other epigenetic assays in medical research. There are currently no commercially available solutions for
analyzing chromatin accessibility in FFPE tissue samples. This type of analysis employs a non-targeted
approach to systematically query open regions of chromatin associated with gene expression, allowing
researchers to broadly understand how changes in chromatin state affect disease progression independent of
alterations in specific histone marks or transcription factor distribution. Triangle’s ChromExtract provides a
workflow that employs an extracellular matrix (ECM)-digesting enzyme cocktail followed by enhanced sonication
using a low-cost, perfluorocarbon (PFC) nanodroplet-based reagent for high-quality, high-yield, and consistent
chromatin extraction from FFPE tissue in any commercially available sonicator. In this Phase I SBIR project,
Triangle Bio will: 1) Demonstrate enhanced cavitation and increased resilience of nanodroplet formulation in
FFPE-based lysis buffers and 2) Optimize and validate the FFPE tissue chromatin extraction workflow for
Formaldehyde-Assisted Isolation of Regulatory Elements (FAIRE) seq. This work will establish the feasibility of
commercializing ChromExtract by demonstrating the ability to enable NGS-based analysis of chromatin
extracted from FFPE samples, producing results that are rigorous, reproducible, efficient, and cost effective. This
will be followed in a future Phase II application by further validation with other downstream NGS-based workflows.

Public health relevance
Narrative Epigenetic changes are recognized as early events for many diseases, and characterization of the epigenetic landscape is pivotal for medical research and carries diagnostic and therapeutic potential. Unfortunately, there are no commercially available solutions for analyzing chromatin accessibility from archival FFPE tissue. ChromExtract, consisting of a combination of sonication-enhancing nanodroplets and a novel extracellular matrix-digesting enzyme cocktail, promises to enhance the quality, consistency, and efficiency and reduce the total cost and time of ultrasonic chromatin extraction, thereby enabling a standardized and commercially viable solution for analyzing chromatin accessibility in FFPE tissues.